The role of transcription factor proteins in mutagenesis at regulatory sites

ABSTRACT
More than 90% of cancer somatic mutations fall in non-coding regions of the genome. While the vast majority
of these mutations are expected to be passengers, a small fraction could act as drivers by disrupting regulatory
interactions between transcription factors (TFs) and DNA, leading to dysregulation of gene expression. Despite
the increased availability of whole-genome cancer somatic mutation data, identifying non-coding driver
mutations in TF binding sites remains a challenge, likely because of gaps in our understanding of the
mutagenic processes acting on regulatory DNA. There is increasing evidence that TFs bound to the genome
can interfere with normal DNA replication and repair, which could lead to increased mutation rates. However,
the precise molecular mechanisms of these interactions are poorly understood. The current project will address
this gap in our understanding of mutagenesis in TF binding sites by using new experimental techniques and
computational models to directly investigate the molecular mechanisms by which TF binding can lead to
genetic mutations. Our overarching hypothesis is that TFs bound to genomic sites containing DNA lesions can
lead to inefficient repair/correction of the lesions, and consequently to increased mutation rates. Among DNA
lesions we will focus on base mismatches, which are important precursors for a majority of cancer mutations,
and are frequently generated in the genome during DNA replication, recombination, and even repair of other
lesions. Thus, mismatches retained in cancer genomes due to being bound by TF proteins are expected to
have a large contribution to the hyper-mutation signal observed at TF binding sites. It is therefore critical to
characterize the TF-DNA binding landscape in the presence of DNA mismatches (Aim 1), and to thoroughly
investigate the mechanisms by which TF binding to mismatches can lead to genetic mutations (Aim 2). Overall,
our proposed work represents a first step toward determining whether the enrichment of cancer mutations in
TF binding sites is due, at least in part, to DNA-bound TFs that act as roadblocks for DNA mismatch correction
and repair. Longer term, a thorough understanding of the role of TFs in mutagenesis at regulatory DNA will be
instrumental for developing accurate methods to identify regulatory driver mutations in cancer.

Public health relevance
PROJECT NARRATIVE Two thirds of genetic mutations that lead to cancer originate from unrepaired replication errors, most commonly mismatched base pairs. Recent studies hypothesized that transcription factor proteins act as roadblocks for DNA repair and replication, leading to mutations in regulatory DNA. The computational models and the experimental approaches developed in this project will lead to a better understanding of how transcription factors and mismatch repair enzymes recognize DNA mismatches, how they compete for binding to mismatches, and how/whether this competition leads to genetic mutations. In the long term, the work proposed here will lead to the development of null models for how mutations are generated in transcription factor binding sites, models that will be instrumental for identifying driver non-coding mutations in cancer.